Hybrid Rat Diversity Program

Project Summary
The ongoing goal of this program is to extend the use of rat models for clinical translation
through establishing an animal resource and genomic dataset to facilitate the translation of
laboratory research to clinical relevance. Specifically, the Hybrid Rat Diversity Panel (HRDP)
resource provides the research community with a foundation for systems genetics and a tool for
forward genetics. To achieve this goal, we propose the following four specific aims: 1) to
continue to establish the 96 strain Hybrid Rat Diversity Panel comprised of 33 classic inbred
strains, 30 HXB/BXH recombinant inbred strains and 33 FXLE/LEXF recombinant inbred strains
through embryo rederivation and importation, 2) to characterize, maintain and distribute the
HRDP, 3) to provide genomic and transcriptomic sequencing of the HRDP and 4) and provide
data analysis, integration and dissemination primarily through the Rat Genome Database
(RGD). This resource will be used to study mechanisms of complex disease traits through
systems genetics by providing investigators with access to a renewable panel of inbred rat
strains and biobanked tissues, reusable phenotypic data, reusable genomic and transcriptomic
data, and the infrastructure to explore, analyze and visualize these resources through the HRDP
Portal at RGD. Experimental rats and biobanked tissues from the entire HRDP panel can be
used for other omic studies, including the epigenome, proteome, and metabolome. The Rat
Resource & Research Center (RRRC) is partnering with the HRDP to provide the rat models to
the research community. The HRDP will have broad utility to the scientific community through
the genetic and phenotypic diversity represented in the 96 strain panel used to study
hypertension, stroke, diabetes, cancer, arthritis, reproductive disorders, asthma, aging, alcohol
preference, anxiety, exercise and addiction.

Public health relevance
Project Narrative This R24 resource grant builds upon our existing infrastructure to develop the 96 strain Hybrid Rat Diversity Panel (HRDP) to be used to broadly study disease mechanisms, the impact of the environment, and for therapeutic drug development. This panel of rats can be used to map complex traits through powerful analyses of genomic, transcriptomic and phenotypic data. In addition, the HRDP provides a genetically stable population that can be reused and renewed.